Enhancing Exercise Intensity, Motivation and Enjoyment for Persons with PD: Comparing Visual Feedback and Competition in A Virtual Cycling Environment (VCYCLE)

Project Summary
In this single group study of 33 persons with Parkinson's Disease (PD, Hoehn and Yahr Stages II-III) will
exercise in two virtual reality augmented bicycling conditions: visual feedback and competition. The primary
purpose of the study is to determine which condition of bicycling (visual feedback or competitive) promotes a
higher exercise intensity in the neuromusculoskeletal domain (measured by revolutions per minutes on the
bicycle) and in the cardiovascular domain (measure by % of max. heart rate) as well as which promotes higher
motivation and enjoyment (measured with the Intrinsic Motivation Inventory) and reduced perception of effort
(measured with the Borg Scale). The secondary aims are to explore how personal factors (competitiveness)
influence the exercise intensity, and whether visual attention can differentiate between the cycling conditions.
Data will be collected in a single session consisting of clinical assessments and bicycling for ten minutes for each
condition while wearing a head mounted display to interact with the virtual environment.
Results from this study will inform the design of optimal exercise programs to make exercise accessible,
enjoyable for persons with PD. Those programs will be tested for efficacy at improving mobility and fitness
leading to well-being for persons with PD.
The proposed project will be undertaken in a well-equipped laboratory under the mentorship of a sponsor
with a long track record of designing virtual reality tools for persons with neurologic health conditions. The
sponsor has successfully mentored dozens of graduate students including dual-degree students, training to be
clinician scientists. Collaborators and contributors from diverse training backgrounds and areas of expertise will
work with the sponsor and PI on this project. The PI will couple his previous training in engineering with new
skills developed in applied science. The PI's training plan includes goals related to research execution and
dissemination, clinical experience, teaching/mentoring, and community/professional service all of which can be
realistically achieved.

Public health relevance
Project Narrative This project will study how virtual reality augmented bicycling using visual feedback and competition will increase exercise intensity, motivation, and enjoyment for persons with Parkinson's Disease. The short-term goal of the study is to select exercise strategies that yield the highest intensity and promote greatest motivation. The long- term goal is to design optimal exercise training programs that are accessible and promote mobility and fitness for persons with Parkinson's Disease so they may maintain a high-level of activity, participation and well-being.